CHARACTERIZATION OF GAGS IN HESCS AND HIPSCS

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. This project involves the characterization of glycosaminoglycans (GAGs) in hESCs and hiPSCs. Changes in the profile of GAGs will be determined as cells differentiate to mesoderm and endoderm lineages. The Dalton lab will provide cells and will perform quality control. Cells will be shipped to the Linhardt laboratory in New York for GAG analysis.